Molecular Targets Modulating Neuro COVID Sequelae Linked to Tauopathy

The COVID-19 pandemic caused by SARS-CoV-2 (CoV2) virus has left a large cohort of individuals suffering
from ongoing neurological sequelae known as neuro-COVID. The condition involves CoV2 neurotropism and
long-term inflammatory responses, including increases in neurodegenerative and neurotoxic proteins such as
tau. Despite progress made, the molecular mechanisms underlying CoV2-induced tauopathy are unknown.
Aging activates innate immune mechanisms and inflammation, and the latter has been linked to tau pathology.
Together these observations have provided a strong scientific premise for this proposal, which aims to investigate
CoV2-induced molecular changes in the context of aging and tauopathy to identify critical mechanisms
underlying the development of neuro-COVID symptoms using mouse models. To this end, data in a mouse-
adapted CoV2-MA10 virus infection in C57BL/6 mice show increased expression of genes involved in
neuroinflammation and tauopathy risk that increase with age, which models neuro-COVID seen in the patient’s
brains. Our preliminary studies led to the identification of two groups of proteins: one involved in protein
misfolding/tauopathy (FKBP51) and the other related to innate immune activation including genes involved in
IFN regulation (IFI204). Our studies also showed that CoV2-MA10 accelerates tau pathology in PS19 tau
transgenic mice, establishing a model to further study tauopathy mechanisms that are accelerated by CoV2.
Most notably, intranasal instillation of dendriplexes (DPX) comprising dendrimers and plasmid encoding short
hairpin RNA (pshRNA) for the lead target FKBP51 in MA10-infected C57BL6 mice significantly reduced
neuroinflammation, and expression of FKBP51 and Tau phosphorylation. These findings lead to the central
hypothesis that age-dependent CoV2 neuro-invasion-induced tau pathology is caused by innate immune
activation and elevated FKBP51 expression. We further hypothesize that CoV2 infection induces similar
inflammation and protein misfolding in PS19 tauopathic mice, accelerating neuropathology and cognitive deficits.
These hypotheses will be tested in the following two specific aims. SA #1 will assess age as a primary variable
that exacerbates inflammation leading to tauopathy and long-term cognitive decline in C57BL/6 mice following
CoV2-MA10 infection. SA #2 will examine the progression of tauopathy in PS19 transgenic mice following CoV2-
MA10 Infection. Each of these aims will: i) characterize neuropathology and behavior; ii) identify target
mechanisms underlying the pathology and neuro-COVID sequelae using spatial transcriptomic profiling; and iii)
validate the role of FKBP51, IFI204 and other novel leads in neuropathological and cognitive consequences,
using DPX formulations carrying pshRNA for these leads. This multi-PI and multi-disciplinary approach to
understanding the mechanisms leading to neuro-COVID is expected to expand our basic knowledge and identify
new mechanistic targets increasing our understanding of the impact of CoV2 on pre-existing age-related or
genetically pre-disposed neurodegeneration.

Public health relevance
About 15-30% of the COVID-19 virus infected population suffer long-term and report ongoing neurological sequelae with diverse neurological manifestations including dementias. Often these dementias result from the abnormal aggregation of tau proteins, called tauopathy, which leads to loss of cognition, as in Alzheimer’s disease; however, the precise molecular mechanism underlying this remains unclear . Herein, we aim to examine the cellular and molecular mechanisms of COVID-induced tauopathy and identify and validate novel lead drug targets toward intervening onset or progression of tauopathy.